Characterization of the Role of Nemo-like Kinase in Normal and Diamond Blackfan Anemia Models of Erythropoiesis.

Summary / Abstract
Diamond Blackfan Anemia (DBA) is a congenital bone marrow failure syndrome associated with
physical malformations and defects in early erythroid progenitors. Over 80% of patients carry mutations in one
of over twenty ribosomal genes, leading to haploinsufficiency and defective global ribosome biogenesis, but
the mechanism by which this leads to erythropoiesis defects is poorly understood. I observed that Nemo-like
Kinase (NLK) is activated in erythroid progenitors with ribosome-insufficiency, irrespective of the driving
ribosomal mutation. Suppression of NLK improves erythroid expansion of hematopoietic stem and progenitor
cells (HSPCs) from DBA patients and mouse models in vitro.
The overarching goal of this proposal is to define the role of NLK in the pathogenesis of DBA and
identify novel upstream regulators and downstream substrates of NLK. Through the acquisition of new skills in
state-of-the-art technologies pioneered by my mentoring team, I foresee the successful resolution of the
proposed research aims and the development of the skillset and preliminary data necessary to establish my
own independent research program. In Aim 1, I will use CRISPR/Cas9 to knock out NLK in ribosome-
insufficient donor HSPCs and examine engraftment after transplantation into recipient mice. As NLK is
activated in DBA models irrespective of the driving mutation, this represents a gene therapy approach for
autologous stem cell transplantation with the potential to cure the hematological impacts of the disease. In Aim
2, I will identify and characterize downstream substrates of NLK in DBA. In Aim 3, I will identify and
characterize deregulated proteins upstream of NLK activation in DBA. The last two aims include
characterization of preliminary candidates, complimented by genome wide screens to identify novel factors.
Collectively, these studies have the potential to identify new therapeutic targets and improve outcomes for DBA
patients.
This proposed work will also provide me with the necessary tools and expertise to successfully
transition to an independent career. Bench skills I will acquire include mouse stem cell transplantation,
CRISPR/Cs9-mediated gene therapy of stem cells, ribosome and mitochondrial biogenesis, translational
analysis and genome-wide kinome analysis. Coursework covering bench skills (e.g. RNA biology, applied
computational tools, and bioinformatics) and career development (e.g. mentorship, personnel management
and faculty transitioning) will compliment guidance from my mentoring team. Dr. Sakamoto has an exemplary
track record of producing leaders and is committed to continued guidance as I take on more autonomy. Dr.
Sakamoto and Stanford have demonstrated exceptional commitment to my professional development
throughout my fellowship and instructor training and I have no doubt their continued support towards our
shared goal of developing a world class independent research program dedicated to understanding the
pathogenesis of nonmalignant hematological disorders such as DBA.

Public health relevance
Narrative Diamond Blackfan Anemia (DBA) is characterized by defective erythropoiesis. Erythroid progenitors from murine and human models of DBA have chronic hyper-activation of Nemo-Like Kinase (NLK), while suppression of NLK improves erythroid expansion in vitro. Understanding the mechanisms by which NLK contributes to disease pathogenesis will potentially lead to novel approaches to treat patients with DBA and other bone marrow failure syndromes.